Development of an Oral Pill to Mimic the Effects of Gastric Bypass Surgery

PROJECT SUMMARY
Obesity is a complex disease that disrupts hormonal and metabolic pathways, increasing the risk of chronic co-
morbidities like diabetes, cardiovascular disease, and cancer. Obesity itself afflicts more than 1 billion globally
and, when combined with its associated risk factors, contributes to over $480 billion in direct annual healthcare
spending. Roux en Y Gastric bypass surgery (RYGB) leverages duodenal nutrient exclusion (DNE) to achieve
best-in-class weight loss results; however, the high costs, extensive procedural risks, and limited reimbursement
have greatly limited access to care. Further, pharmacotherapies and weight loss devices have failed to strike a
balance between affordability and efficacy, which has both limited adoption and widened socioeconomic access
disparities. As such, there is a pressing need to develop novel weight loss interventions that can achieve best-
in-class results while maintaining attractive safety and cost profiles. Using technology licensed from MIT, Syntis
Bio has created a gastrointestinal synthetic epithelial lining (GSEL) that is administered orally and leverages
endogenous enzymes to form a robust muco-adhesive coating specific to the duodenal epithelium. When co-
formulated with cross-linking nanoparticles, GSEL creates a semi-permeable barrier capable of blocking nutrient
absorption (GSEL-Barrier). The goal of this proposed project is to create a once-daily oral pill that blocks nutrient
absorption in the duodenum, thereby mimicking the effects of RYGB. Thus far, GSEL-Barrier has demonstrated
the ability to reduce glucose absorption by 70% in pigs when challenged with an oral glucose tolerance test
(OGTT). In this Fast-Track SBIR proposal, we seek to expand on this this early pig work to further optimize GSEL
composition for barrier formation, engineer GSEL into solid tablet formulations, and test efficacy in beagles which
more closely reflect human gastric emptying times. Successful completion of these aims will yield optimized solid
dosage form tablets that have been validated in large animals and are ready for first-in-human testing. Syntis
will then be ready to start scaling GMP manufacturing as well as initiate GLP pre-IDE studies in preparation for
first-in-human trials.

Public health relevance
NARRATIVE Obesity is a global disease with significant healthcare spending and co-morbidities, highlighting the need for effective, non-invasive, and affordable weight loss solutions. Roux-en-Y gastric bypass surgery (RYGB) the gold standard for weight loss, but is limited by its high cost and procedural risks. Syntis Bio has created a gastrointestinal synthetic epithelial lining (GSEL) that is orally administered and transiently blocks nutrient absorption in the small intestine, thereby safely mimicking the effects of RYGB. This project aims to further develop the GSEL as an effective, safe, and affordable therapeutic weight loss intervention.